Genetic testing to guide pediatric cancer care and follow up: using anthracycline-associated cardiac toxicity as a model for the future

PROJECT SUMMARY/ABSTRACT
Recent genomic advances have identified a potential for germline risk markers to predict risk of treatment-
related toxicity in children treated for cancer. Although advances in pediatric cancer treatment have led to
remarkable increases in survival rates, long-term morbidity and early mortality risks underscore the need for
new approaches that minimize late toxicities while maintaining disease control; using genetic markers to
predict risk and change therapy represents a potential strategy to reduce adverse outcomes. Genetic risk
assessment has created great excitement about the possibility of individualized therapy adapted for patients
who carry increased or decreased risk. For example, research in cancer survivor cohorts have demonstrated a
five-fold increased risk of congestive heart failure and a seven-fold increased risk of premature cardiac death.
Clinical practice recommendations have recently been published for individualized adaptation of treatment and
surveillance based upon genetic cardiac-risk profile in childhood cancer patients receiving anthracycline
therapy. However, considerable uncertainty surrounds how successfully genetic information may translate into
improved care and outcomes for children with cancer. Further, the rarity of childhood cancer and the long
latency needed to observe late outcomes limit the feasibility of prospective trials to evaluate a precision-
medicine approach to care and follow-up. We propose to employ a decision-analytic modeling approach to
determine how genetic testing may inform clinical care, both of initial cancer therapy and post-treatment care
based on individual susceptibility for cardiotoxicity. We will develop a novel, flexible microsimulation model of
the clinical course of childhood cancer to project the full spectrum of health outcomes relevant to the childhood
cancer, including initial disease control and treatment-related late toxicities, and then incorporate genetic data
to assess the impact upon these outcomes. This modeling framework will integrate data from multiple
resources, including the Childhood Cancer Survivors Study (CCSS) to (1) project long-term outcomes for
children diagnosed with cancer; (2) determine the clinical impact of utilizing genetic variant testing for
cardiotoxicity in guiding cancer care; and (3) assess how consideration of genetic markers can improve follow-
up cardiac screening recommendations for at-risk survivors. We aim to portray the scope and nature of the
uncertainties that surround model parameters and their impact on modeled outcomes by employing
bootstrapping methods, statistical methods to extrapolate cardiotoxicity risks, and rigorous approaches to
uncertainty analysis. By uniquely leveraging the CCSS data to characterize the lifelong treatment-related
cardiotoxicity risks, our proposed research will establish a novel analytic framework for evaluating the
uncertainties and tradeoffs surrounding the use of genetic testing in pediatric oncology, and form the basis for
understanding the impact of genetic risk testing for other toxicities.

Public health relevance
PROJECT NARRATIVE Genetic markers for anthracycline-related cardiotoxicity may provide the basis for guiding initial therapy choice and follow-up care for children with cancer. By developing a flexible analytic modeling framework capable of capturing the wide spectrum of short- and long-term health outcomes, ranging from initial disease control to treatment-related late toxicity in adulthood, this project aims to evaluate the clinical benefits and risks associated with genetic testing at time of cancer diagnosis in the era of cancer genomics.